Novel regulatory regions within the immunoglobulin kappa locus

DESCRIPTION (provided by applicant): The Igκ locus produces a wide array of Ig kappa light chain rearrangements, but how this complex process is regulated is not known. The creation of a diverse Igκ repertoire is facilitated by major changes in the 3-dimensional structure of the Igκ locus called locus contraction that occur at the time of rearrangement. This compaction allows Vκ genes throughout the locus a chance to come into proximity with the Jκ genes to which one Vκ gene will rearrange in each pre-B cell. However, the factors which are important in orchestrating the 3D structure and long-range looping interactions of the Igκ locus in pre-B cells are not known. Furthermore, how the 3D structure affects Vκ gene utilization is not known. We have performed ChIP-seq in RAG-/-μ+ pre-B cells for a variety of histone posttranslational modifications, including H3K4me1, the characteristic epigenetic mark of enhancers. It was surprising to observe that there were so many peaks of H3K4me1 within the Vκ locus, most of which are not present in pro-B cells. This developmental stage-specificity of the H3K4me1 regions suggests that these regions may play a role in regulating Vκ rearrangement. Published studies indicate that there are some regions within the Vκ locus that are preferential sites of long-range interactions with iEκ, the enhancer located just downstream of the 4 Jκ genes. We found that the most predominant long-range interaction hubs are characterized by broad regions of high H3K4me1, and ChIP-seq reveals that these hubs demonstrate binding of multiple key transcription factors (TF) such as Pax5, EBF, E2A, Ikaros, PU.1 or YY1. We therefore hypothesize that some of these putative novel regulatory elements will be important in regulating the composition of the Igκ repertoire, possibly by orchestrating the 3D configuration of the contracted Igκ locus. We will assay these regions for traditional enhancer activity in a pGL3 luciferase vector. Specific TF binding sites within the enhancer regions will be mutagenized to determine which TF are essential for enhancer activity. To test our hypothesis that these regulatory regions will influence V gene repertoire composition, possibly by altering the 3D structure of the locus, we will delete putative regulatory regions, and also mutate individual TF binding sites within these regions, in an Abelson pre-B cell line, using CRISPR/Cas9 PrecisionX homologous recombination genome editing technology. Culture of the Abl pre-B cell line with the Abl-kinase inhibitor STI571 for 48 hours robustly induces a diverse repertoire of Igκ rearrangements. The effects of the deletions or mutations on long-range interactions will be assayed by 3C, and changes in the Igκ repertoire will be assayed by TaqMan real time PCR and by deep sequencing. We hypothesize that deletion of key TF binding sites and/or larger regulatory regions with binding sites for several key TF will profoundly affect the resulting Igκ repertoire. Whether this effect will be predominantly of genes in the vicinity of each enhancer/TF binding site cluster, or more globally, will be determined. This would demonstrate a highly novel function for these elements bearing the epigenetic characteristics of traditional enhancers.

Public health relevance
PUBLIC HEALTH RELEVANCE: The establishment of a diverse repertoire of antibodies is essential for the immune system to combat a wide variety of pathogens. Here we will study new regulatory elements that may orchestrate the V(D)J recombination process by which the light chain genes of antibodies are assembled. The large scale movement of the Ig loci during rearrangement places it in close proximity to other genes including oncogenes, and inappropriate regulation of the double-strand DNA breaks that occur during V(D)J recombination can then result in translocations of those oncogenes with Ig genes resulting in lymphomas and leukemias.